PATHOGENESIS OF DISEASE CAUSED BY INFECTION WITH INTRACELLULAR PARASITES

This project focuses upon the different clinical forms of leishmanial infections in humans, immune responses to the parasite, with particular reference to cell-mediated responses and the cytokine regulation of these responses, and characteristics of the causative parasites. Of the 12 patients referred to NIH and cultured for leishmania, only 4 were positive and treated. No explanation could be found for the striking increase in serum lipase and amylase that occurred in association with pentavalent antimony treatment. Tests of cell-mediated immune function (delayed hypersensitivity skin tests and lymphocyte proliferation assays) were carried out in a total of more than 50 Persian Gulf military returnees. No completely satisfactory method of retrospective immunologic diagnosis of leishmanial infection was found for this group of patients, although a number of suggestive cases were identified. Further semi-quantitative assays for mRNA of various cytokines in the bone marrow of visceral leishmaniasis patients are planned. A controlled clinical trial of topical therapy for cutaneous leishmaniasis in Honduras is under evaluation.